Creating tools to make experimental biochemistry accessible to people with blindness

Project summary. People with blindness and low vision (BLV) experience systemic exclusion from
biomedical science because the tools of experimental science—and the data they produce—are
inaccessible. The two central hypotheses of this proposal are: (i) the tools and information of an
experimental biomolecular research lab can be made accessible to people with BLV with interventions
that incorporate universal design, and (ii) persons with BLV can use these tools to test biomedical
hypotheses and publish their results in peer-reviewed journals. This project has four aims; two aims for
developing assistive technology, and two aims to use this technology to test hypotheses about (i)
heteromeric interactions between wild-type (WT) Cu, Zn superoxide dismutase (SOD1) and mutant
forms of SOD1 that cause amyotrophic lateral sclerosis (ALS), and (ii) redox properties of mitochondrial
redox enzymes. In aim 1, we plan to methodically make each tool/technique in the PI’s lab accessible,
beginning with SDS-PAGE and Western blotting, protein purification, capillary electrophoresis, PCR, and
touch screen devices (pH meters, centrifuges). Assistive technology is being designed and 3D printed
in the PI’s lab, including a device that enables researchers with total blindness to autonomously load
SDS-PAGE gels by hand. Robotic devices that weigh solids and initiate biochemical reactions are also
being made accessible. In aim 2, graphical imagery and data (electropherograms, spectra, electron
micrographs) are converted into lithophanes (engravings that provide tactile readouts and optical
readouts via light scattering). Haptic gloves—developed for gaming—will be adapted to help researchers
with blindness visualize virtual objects (protein structures, CAD files, etc.). In aim 3, these tools will be
used by blind and sighted researchers to test how incorporation of WT SOD1 into fibrillar mutant SOD1
affects its kinetic, thermodynamic, and structural properties. Here, fluorescence spectroscopy, amide
H/D exchange, chemical crosslinking and cryo-electron microscopy will be used to test the hypothesis
that WT SOD1 incorporates into mutant fibrils to alter their structure/morphology, stability and
propagation rate. In aim 4, “protein charge ladders,” capillary electrophoresis, and site directed
mutagenesis will be used to test the hypothesis that long-range electrostatic interactions in mitochondrial
metalloproteins play a dominant role in controlling their redox properties. Each aim is developed for (and
in collaboration with) faculty and researchers who have early blindness and persons with late blindness,
who developed blindness as adults after Ph.D. training in biomedical science (these latter persons have
been forced to drop out of science). This project involves a collaborative team of sighted and blind
biochemists, chemists, electron microscopists, and computer scientists, including undergraduate, post-
doctoral, and independent scientists with blindness currently in the PI’s lab.

Public health relevance
Project narrative: The imagery, data and experimental tools of biomedical science are inaccessible to people with blindness, leading to systemic exclusion. This proposal is utilizing universal design to create and test new technology to make data and laboratory tools of molecular science accessible to lab members with blindness (and other people with blindness). The tools will then be used by sighted and blind members of the PI’s lab to test biomedical hypotheses in bioinorganic and biophysical chemistry.